Targeting Atr to promote regeneration and functional recovery after neural injury

Failure of damaged axons to regenerate and reestablish functional circuitry is the primary cause that results in
permanent disabilities after central nervous system (CNS) injury, and is also a major factor contributing to the non-­reversible neurologic dysfunction seen in neurodegenerative diseases. Of approximately 1.9% of the U.S.
population with paralysis, some 1,275,000 are paralyzed as the result of a spinal cord injury (SCI). SCIs
frequently result in at least some incurable impairment even with the best possible treatment and patients with
complete injuries recover very little lost function. Under pathological situations such as multiple sclerosis, the
second most common neurological disorder leading to disability in young adults, failure of damaged axons to
regenerate contributes to neurologic abnormalities. Despite ample efforts in the past few decades, which have
led to the discoveries of extracellular factors that impede, and intrinsic pathways in mature neurons that diminish
the regenerative capacity of axons, effective therapies have not emerged given the fact that simply removing
those inhibitory cues confers limited regrowth and that our understanding of neurons’ intrinsic regenerative
properties still remains incomplete, indicating that additional regulatory machinery must be in place. This
highlights the urgent need to identify novel molecular targets for therapy.
With the goal to find novel factors essential for CNS axon regeneration, we have utilized a Drosophila sensory
neuron injury model that resembles mammalian injury at the phenotypical and molecular level in a candidate-­
based genetic screen, and identified the Piezo-­Atr (Ataxia telangiectasia and Rad3 related) pathway as inhibitors
for axon regeneration. This proposal aims to determine the cellular and molecular mechanisms underlying Piezo-­
Atr’s function in flies and to elucidate the role of the mammalian Atr after peripheral or spinal cord injury. Atr is
an essential component of the DNA damage response and also responds to mechanical force. This pathway
has never been implicated in axon regeneration, and our study will thus provide exciting insights into the potential
links among axon injury, DNA damage response, mechanosensation and regeneration, and will open new
avenues of research for regeneration and spinal cord injury. Taking advantage of the power of fly genetics to identify novel factors and the mammalian injury model, this strategy offers a unique opportunity to gain insights
into the repertoire of regeneration regulators, which may drive novel treatments to promote recovery in patients
with neural injury or neurodegenerative diseases.

Public health relevance
Central nervous system injury such as spinal cord injury is refractory to repair, attributed to the reduced neuronal intrinsic regeneration capacity and a hostile microenvironment. Understanding the mechanisms that inhibit or promote neural regeneration is relevant to public health because it will ultimately lead to treatments for neural injury and neurodegenerative diseases. The Atr (Ataxia telangiectasia and Rad3 related) pathway was previously known to regulate DNA damage response, but here we describe a remarkable new function of this pathway in inhibiting neural regeneration that links neural regeneration to mechanosensation, and propose Atr as a novel therapeutic target for neural injury, with drugs already in clinical trials as anticancer therapy.